Development of a clinically relevant mouse model of ER+ breast cancer

The purpose of this proposed R21 project is to develop and validate a novel, clinically relevant mouse model
for estrogen receptor-positive (ER+) breast cancer. Most human breast cancers are ER+ and are treated by
endocrine therapy. Current clinical challenges for treating ER+ breast cancer include: 1) some patients do not
respond to or develop resistance to endocrine therapy; 2) some patients eventually progress to ER+
metastatic breast cancer. Animal models that can faithfully recapitulate the biology of ER+ breast cancer are
essential for addressing these challenges in a preclinical setting. However, current in vivo models are
inadequate. It remains an unmet clinical need to more faithfully model ER+ breast cancer under the
physiological setting. The failure to model ER+ breast cancer faithfully in animals (e.g., mice) may be due to:
1) oncogenic events are not targeted to the correct cellular origin; 2) oncogenic mutations specifically
associated with human ER+ breast tumors are rarely modeled in mice. Taking these into consideration, we
recently developed a new mouse model for ER+ breast cancer based on a recurrent genetic mutation uniquely
found in human ER+ breast tumors, i.e., loss-of-function mutation or deletion of an estrogen/ER signaling-
related transcription factor gene, RUNX1. The model is based on intraductal injection of a Cre-expressing
adenovirus (Ad-Cre) under the control of the Keratin 8 promoter (Ad-K8-Cre) to female mice carrying
conditional knockout alleles of Runx1 and p53. Ad-K8-Cre-induced loss of RUNX1 and p53 in K8+ luminal
mammary epithelial cells (MECs) led to development of ER+ mammary tumors with hyperactive ribosome
biogenesis and immune responses, which are also observed in human RUNX1-deficient ER+ breast cancers.
However, since Ad-K8-Cre targets both ER+ and ER- luminal MECs and the resulting tumors exhibited
features of both ER+ and Claudin-low (i.e., tumor cells with mesenchymal-like appearance) cancers, it is
unclear whether the mixed tumor phenotype is due to their different cellular origins (e.g., ER+ vs. ER- luminal
MECs) and/or due to p53-loss (which promotes cell fate plasticity). We hypothesize that in order to make this
model more clinically relevant to human ER+ breast cancer, it can be further improved by inducing RUNX1-
loss and its cooperating oncogenic events (i.e., other than p53-loss) specifically in ER+ luminal MECs (i.e.,
the potential cellular origin of ER+ breast cancer). To address this, two Specific Aims are proposed. Aim 1
will focus on developing a new Ad-Cre tool to specifically target Cre expression to the ER+ luminal sublineage,
so that mammary tumorigenesis is initiated only from ER+ luminal cells. In Aim 2, we will test if oncogenic
events affecting the RB-E2F pathway (as hyperactive ribosome biogenesis may lead to ribosomal stress,
which may cause cell cycle arrest via this pathway) would cooperate with RUNX1-loss, leading to ER+
mammary tumors from luminal MECs. The successful development of such model would provide an
invaluable tool for better understanding the biology and therapy of ER+ breast cancer.

Public health relevance
Breast cancer is the most common type of cancer in women and the majority of breast tumors in patients are positive for estrogen receptor (ER). The purpose of this R21 project is to develop a more clinically relevant mouse model of ER+ breast cancer based on a genetic mutation specifically found in human ER+ breast tumors. Successful completion of this project is expected to lead to a better in vivo model for studying the biology and therapy of ER+ breast cancer.